Antemortem White Matter Integrity Quantification from DTI and Relationship with Postmortem TDP-43

Project Summary/Abstract
Dementia syndromes are global health concerns affecting more than 55 million people worldwide, with an
estimated 10 million new cases each year. Without a cure or therapeutic agents to stop the progression of
disease, dementia remains a devastating illness which requires significant exploration. White matter
microstructure is significantly affected within dementia, however, the relationship between underlying disease
and microstructural integrity is poorly understood. Indeed, understanding neurobiological basis underlying
cognitive decline in neurodegenerative disease remains an unmet challenge. There is a dearth of research on
the relationship between antemortem brain characteristics and postmortem disease burden. TAR DNA-binding
protein 43 (TDP-43) proteinopathy is a common feature of many neurodegenerative diseases, is known to affect
white matter structural integrity, and needs to be explored in-vivo. While in addition to neuronal pathology, TDP-
43 is also highly involved in white matter and therefore, studying the relationships between TDP-43 and white
matter structural integrity can allow for a better understanding of the neurodegenerative process. Utilizing a
community-based sample of older adults from two cohort studies from the Rush Alzheimer’s Disease Center, I
plan to measure the relationship between postmortem TDP-43 pathology and spatial antemortem white matter
structural integrity and additionally explore its effect on cognition. Traditional measures of white matter integrity
assume the entire tract to maintain similar characteristics, however, advanced computational research has
identified that white matter integrity varies in stereotyped patterns along the tract. By studying the relationship
between postmortem TDP-43 burden and spatial patterns of antemortem white matter integrity, we can assess
localized white matter integrity as it relates to disease burden. I will then explore the association of white matter
integrity and cognition through correlation and mediation analysis. No previous research has utilized postmortem
neuropathological burden quantification to measure disease effects on in-vivo spatial white matter integrity. By
exploring the relationship of postmortem quantification of TDP-43 burden and antemortem white matter structural
integrity, we may enhance our understanding of the role of disease within the neurodegenerative process. Future
research can expand this research to be used as a potential noninvasive, readily available, antemortem
biomarker indicative of postmortem disease.

Public health relevance
Project Narrative The effect of TDP-43, a neurodegenerative pathology highly involved in neurodegenerative disease, on the structural integrity of the brain is poorly understood. This project aims to explore the relationship of TDP-43 pathological burden, spatial white matter integrity of fiber tracts known to be involved in dementia syndromes, and cognition, by utilizing antemortem neuroimaging and postmortem neuropathological quantification. Not only will results from this study inform the field on the effect of pathology on structural connections of brain networks in an older adult population, results from this study could also be used to develop a readily available, non-invasive biomarker for TDP-43 pathology which currently does not exist.